EFFICACY OF SABRIL VS CARBAMAZEPINE IN MANAGEMENT OF PARTIAL SEIZURES

The purpose of this study is to evaluate the effectiveness, safety and impact on the quality of life while receiving Sabril compared to Carbamazepine.